Novel DNA Repair Inhibitors for Cancer Therapy

Project Summary/Abstract.
We seek to identify novel therapeutic agents that are selectively toxic to cancer cells and that specifically
sensitize tumors to radiation or chemotherapy. We have discovered that a cell-penetrating, lupus-derived
autoantibody (3E10) increases the sensitivity of cancer cells to radiation and to DNA-targeted chemotherapy.
Importantly, 3E10, by itself, is synthetically lethal to BRCA2- and PTEN-deficient cancer cells, but is otherwise
non-toxic to cells in culture or to mice. The antibody also showed no detectable toxicity in humans when tested
in a phase I clinical trial in lupus patients as a putative anti-idiotype vaccine. We previously determined 3E10 to
be a potent inhibitor of homology-dependent repair (HDR), and we have now identified RAD51 as the
functional target. We have also found that 3E10 is preferentially taken up in tumor tissue in vivo based on its
mechanism of cell penetration, providing a further basis to pursue its development for cancer therapy. These
new results provide the basis to enhance the potency of 3E10 (by directed mutation, affinity maturation, and
multi-valent constructs) and to rationally develop therapeutic strategies by identifying synthetic lethal
interactions (via unbiased shRNA dropout screen and interrogation of curated cancer cell lines) and
determining synergies with other agents, as a prelude to pre-clinical animal tumor studies. We expect that
3E10 will be synthetic lethal to cancers deficient in DNA repair and damage response pathways.
We also have developed a strategy to selectively target DNA repair inhibitors to tumors by exploiting the
acidic tumor microenvironment. We will use a pH low insertion peptide (pHLIP) that inserts directionally across
cell membranes at low pH and delivers cargoes selectively into tumor cells in vivo. Focusing on DNA-PK in the
non-homologous end-joining pathway (NHEJ) of DNA repair, we will build on advances made in collaborative
work to develop tumor-targeted antisense and small molecule inhibition of DNA-PK. We will incorporate next
generation γPNAs modified at the γ position to increase binding to RNA for potent antisense activity. This is
based on our promising proof-of-concept studies published in Nature demonstrating the in vivo anti-tumor
activity of pHLIP-PNA conjugates. We will also conjugate small molecule DNA-PK inhibitors to pHLIP,
leveraging potent molecules that have not advanced to the clinic because of normal tissue toxicity, and
conferring tumor selectivity. This work will provide a versatile platform to apply to other DNA repair targets.
We have recently identified the oncometabolite, 2-hydroxyglutarate (2HG), as a new biomarker of deficient
DNA repair in human malignancies. We found that elevated levels of 2HG confer a BRCAness phenotype of
deficient HDR that renders cancer cells sensitive to synthetic lethal killing by PARP inhibitors and by 3E10.
2HG is produced by the neomorphic activity of isocitrate dehydrogenase-1 and -2 (IDH1/2) mutations found in
gliomas, leukemia, and other cancers. We will investigate the mechanism by which 2HG suppresses DNA
repair and identify vulnerabilities that can be exploited for therapeutic gain in human tumors.

Public health relevance
Project Narrative. We seek to identify novel therapeutic agents that are selectively toxic to cancer cells and that specifically sensitize tumors to radiation or chemotherapy. We have discovered that a lupus-derived, cell-penetrating autoantibody (3E10) inhibits DNA repair and can increase the sensitivity of cancer cells to radiation and chemotherapy but is otherwise non-toxic to human cells. We have also developed novel peptide conjugates that selectively target tumors and spare normal tissues, and we will use these to deliver specific DNA repair inhibitors to cancer cells. We will investigate the mechanism of action of these agents and elucidate how they can best be used for cancer therapy.